Affordable Robot-Based Assessment of Cognitive and Motor Impairment in People Living with HIV and HIV-Stroke

PROJECT SUMMARY
About 37 million people live with human immunodeficiency virus (HIV) worldwide and about 71% of people living
with HIV (PLWH) reside in low and middle income countries (LMICs). HIV enters the central nervous system
(CNS) early after infection and increases the risk for mild-to-severe neurocognitive and cardiovascular disorders.
Studies show that about 30 to 40% of PLWH will have neurologic complications leading to long-term motor and
cognitive disability, including HIV-Associated Neurocognitive Disorders (HAND). Few studies have examined
how best to provide objective assessment, diagnostic, and rehabilitative treatment tools to aid people living with
disabilities as a result of HIV and HIV-stroke in LMICs. The need for these tools is great in LMICs, given the
greatly limited infrastructure and healthcare resources and thus decreased access to consistent, quality
rehabilitation. Our long-term goal is to develop innovative and affordable robot technologies to bridge healthcare
care gaps in LMICs and leverage them to help objectively assess, diagnose and treat PLWH presenting with
motor and cognitive impairment due to HAND and Stroke. In this R21 project, we leverage our affordable
robot therapy system augmented with objective metrics and motor and cognitive exergames to assess
PLWH in Botswana—a country with the fourth highest HIV prevalence rate (20.3%) in the world, an increasing
NCD prevalence rate, and limited rehab resources. Aim 1 determines concurrent validity and reliability of using
the robot therapy system to objectively ASSESS cognitive, and motor impairments in PLWH. Forty (40) PLWH
and 40 HIV-negative controls will be evaluated using both clinical metrics and new robot-based metrics at two
time points, at least 1-week apart. We hypothesize that robot-based metrics will have test-retest reliability as well
as concurrent validity with clinical measures of motor and cognitive function that usually require rehabilitation
expertise and man-power to complete. Aim 2 determines the feasibility of developing a robot-based classification
of HIV-associated neurocognitive disorders (HAND). 80 PLWH without stroke will be evaluated using an
augmented neuropsychological (NP) battery required to meet minimal HAND Frascati criteria and the robot
assessment tasks. We will use the Frascati criteria and global deficit scoring (GDS) to classify the PLWH
participants into asymptomatic neurocognitive impairment (ANI), mild neurocognitive disorder (MND) and HIV-
associated dementia (HAD). We will develop a regression model using derived robot metrics and test its ability
to predict HAND and GDS score. We hypothesize that the robot-based model will classify HAND with specificity
and sensitivity better than HAND screening with International HIV Dementia Scale and Montreal Cognitive
Assessment. The Receiver Operator Curve (ROC) will be used as empirical validation. Demographic, HIV, and
lifestyle factors such as age, viral load, hypertension, diabetes, hepatitis C, and tobacco will be used to determine
which increased the risk for HAND.

Public health relevance
NARRATIVE Due to extremely limited infrastructure and healthcare resources, motor and cognitive impairments in general and HIV-Associated Neurocognitive Disorders (HAND) in particular often go undiagnosed in people living with HIV (PLWH) and non-communicable diseases (NCDs) in Low and Middle Income Countries (LMICs). Novel and affordable technology-based strategies are needed to offer both evaluation and treatment. In collaboration with partners in Botswana, where the prevalence of both HIV and NCDs is high, we seek to determine the feasibility, acceptability and preliminary efficacy of an innovative and affordable robot-assisted solution to objectively assess and diagnose motor and cognitive impairments after HIV and HIV-Stroke.